Microbiota, Probiotic and Dietary Metabolite Control of Enteric Pathogen Virulence

PROJECT SUMMARY
Key metabolites from microbiota, probiotics and diet can inhibit the virulence properties of enteric pathogens,
but their mechanisms of action are unclear and limit the development of new anti-infectives. To determine the
mechanism(s) of action of prominent microbiota metabolites (short chain fatty acids, aromatic amino acids, bile
acids and others), multi-disciplinary approaches are needed to biochemically identify metabolite-protein targets
in enteric pathogens and characterize their activity on infections in vivo. My laboratory will therefore employ
innovative methods in chemical biology, proteomics and gene editing in bacteria to elucidate how specific
metabolites attenuates enteric pathogen infections. A better understanding of how these metabolites affects the
virulence properties of bacterial pathogens should reveal potential therapeutic targets and facilitate the
development of new anti-infectives to combat bacterial pathogens in animals and humans.

Public health relevance
PROJECT NARRATIVE Metabolites from the microbiota, probiotics and diet can inhibit the virulence of bacterial pathogens, but their mechanisms of actions have been not fully elucidated. Using innovative chemical biology, proteomic and gene editing methods, we will determine the protein targets of prominent bacterial and dietary metabolites and evaluate how they attenuate the virulence mechanisms of bacterial pathogens. Understanding how key metabolites affects bacterial pathogenesis may afford new therapeutic targets and anti-infective agents.